Environmental Epigenetics of EDCs: From Germline to Brain

ABSTRACT
Exposures to environmental endocrine-disrupting chemicals (EDCs), especially during early life, are strongly
linked to adverse health outcomes including neurobehavioral, reproductive, and other endocrine dysfunctions.
EDC exposures to a fetus (F1) also exposes the germline and causes heritable epigenetic changes that are
passed to future generations. There are a number of limitations to prior work that I will overcome in the current
RIVER application. Most EDC research is limited to a single tissue type or a single mechanism with a limited
number of targets. This is particularly complicated in the brain because of its heterogeneity. The field is also
limited by a surprisingly small number of studies that compare sex differences, yet EDCs have profoundly
different effects on the developing male and female brain, body, and germline, which are subject to sex-specific
epigenetic programming and therefore sex-specific phenotypes. Finally, how epigenetic programming
propagates from gamete to somatic cells and causes tissue-specific diseases such as neurobehavioral disorders
is a fundamental question, one that (to my knowledge) has never been addressed. This RIVER application has
three overarching areas of inquiry. 1) What are the epigenetic mechanisms by which environmental EDCs
organize brain development at the cellular level, and lead to functional neurobiological deficits in exposed
individuals? 2) Which epigenetic mechanism(s) is responsible for programming of the germline to enable
transmission across generations? 3) How does epigenetic programming in the germline manifest as cell-specific
phenotypes in somatic cells (e.g. brain)? To address these questions we will use our established rat EDC
exposure model with human-relevant chemicals, dosages, and route, in which direct (F1), intergenerational (F2),
and multigenerational (F3) work will be performed in both the brain and the gametes. I am uniquely qualified to
lead this research program as an environmental neuroendocrinologist doing groundbreaking multigenerational
epigenetic work. We will do single-cell multiomic profiling of both the brain and gametes at the RNA, DNA, and
small-noncoding RNA (sncRNA) level, enabling us to pinpoint the cell types influenced by EDCs, and how
phenotypes are propagated from gametes to individuals and across developmental stages. Established
bioinformatic pipelines will inform on these mechanisms individually, as well as their relationships. Crucially, the
lines of work in brain and gametes will be connected by relating epigenomic profiles in brain and germ cells to
one another, thereby determining how epigenomic marks in gametes are reflected in the brain. These data will
establish definitive epigenetic profiles that will allow us to identify the origin of EDC induced epigenetic
modifications and provide potential targets for therapeutics in humans, with which the mechanisms studied in
rats are highly conserved. The flexibility and security of the RIVER program is necessary to fully realize the
promise of this likely paradigm-shifting research.

Public health relevance
PROJECT NARRATIVE All humans are exposed to environmental endocrine-disrupting chemicals (EDCs) from industry, agriculture, and plastics. Experimental animal studies and epidemiological data in humans show that EDC exposures during hormone-sensitive periods early in life can change how the brain develops, and at the same time, affect future generations through actions on the germline (precursors to sperm and eggs). By identifying the molecular mechanisms by which developmental EDC exposures cause epigenetic changes in exposed individuals and their descendants, the proposed work has the potential to inform interventions for exposed humans and their offspring.